Residential Wood Smoke Interventions Improving Health in Native American Populati

DESCRIPTION (provided by applicant): A critical need exists for efficient community-based interventions aimed at reduction of environmental exposures relevant to health. Biomass smoke exposures due to residential wood heating are common among rural Native American communities, and such exposures have been associated with respiratory disease in susceptible populations. In many of these communities wood stoves are the most economic and traditionally preferred method of residential heating, but resource scarcity can result in burning of improper wood fuels and corresponding high levels of indoor particulate matter. In response to the funding announcement Interventions for Health Promotion and Disease Prevention in Native American Populations (PAR-11-346), we propose a two-level intervention strategy to reduce exposure to indoor biomass smoke among elderly tribal members in two reservation communities: Nez Perce and Navajo Nation. Community-based participatory research techniques will be used to adapt intervention approaches to meet the cultural context of each participating community. At the community level, we will facilitate local development of a tribal agency-led wood bank program ensuring that elderly and/or persons with need have access to dry wood for heating. At the household level, we will use a three arm randomized placebo-controlled intervention trial to implement and assess education/outreach on best burn practices (Tx1). The content and delivery strategies of the education intervention will be adapted to each community according to stakeholder input. This educational intervention will be evaluated against an indoor air filtration unit arm (Tx2), as well as a placebo arm (Tx3, sham air filters). Tx3 will be used in comparison with the other two treatment arms to evaluate the penetration and efficacy of the community-level wood bank program. Outcomes will be evaluated with respect to changes in pulmonary function measures and respiratory symptoms and conditions among household elders. We hypothesize that locally-designed education-based interventions at the community and household levels will result in efficacious and sustainable strategies for reducing personal exposures to indoor particulate matter, and lead to respiratory health improvements in elderly Native populations. This study will advance knowledge of cost-effective environmental interventions within two unique Native American communities, and inform sustainable multi-level strategies in similar communities throughout the US to improve respiratory health among at-risk populations.

Public health relevance
Lung function is an important determinant of long-term health, and exposure to particular matter is known to adversely impact lung function. This study will test community-based exposure reduction strategies in tribal households that use wood stoves for home heating and evaluate the corresponding impact on respiratory function among elderly residents.